Supporting Treatment Access and Recovery for Co-Occurring Opioid Use and Mental Health Disorders (STAR-COD)

PROJECT SUMMARY / ABSTRACT
Opioid use has dramatically increased in the United States since 2000, and disproportionally affects individuals
with co-occurring mental health disorders (COD). Individuals with COD are vulnerable to substance use relapses,
mental health symptom exacerbations, opioid overdoses, suicide, homelessness, and criminal justice
involvement. Although medication for opioid use disorder (MOUD) is the gold standard of care, engagement
rates are as low as 18% which negatively impact outcomes. In addition, there is mixed evidence regarding the
incremental therapeutic benefit of adding single behavioral interventions to improve MOUD outcomes, despite
being recommended in clinical practice guidelines. Furthermore, while multi-component interventions exist, little
is known about their incremental therapeutic effect on outcomes in conjunction with MOUD and standard medical
management for those with a COD. Maintaining Independence and Sobriety through Systems Integration,
Outreach and Networking (MISSION) is one such multi-component, cross-disciplinary, team-based treatment
approach, combining 3 evidence-based practices along with MOUD: 1) Dual Recovery Therapy (DRT), which is
integrated group therapy for COD; 2) Peer Support (PS), offering support for people in recovery by people in
recovery; and 3) Critical Time Intervention (CTI), a time-limited form of assertive community treatment. Although
the effectiveness of MISSION is well established, given the difficulty with implementation uptake in large systems
due to its complexity and the need to improve outcomes for those with a COD who receive MOUD, a critical next
step is to understand the incremental therapeutic benefit of MISSION + MOUD, and identify highest value
MISSION components that drive the largest clinical improvement and offer the greatest return on investment.
In response to RFA-MH-21-145, the proposed 4-year study with a half fractional factorial design, “Supporting
Treatment Access and Recovery for Co-occurring Opioid Use and Mental Health Disorders (STAR-COD),” will
randomize 1,000 patients with COD across 9 MOUD programs to the following 5 conditions: 1) MOUD alone; 2)
full MISSION protocol (CTI & DRT & PS) + MOUD; 3) CTI & DRT + MOUD; 4) PS & DRT + MOUD; or 5) CTI &
PS + MOUD. There are four specific aims. Aim 1: To evaluate the effectiveness of MISSION or its components
with MOUD versus MOUD alone, as well as the incremental benefits of MISSION or bundled parts + MOUD to
improve engagement, substance use and mental health symptoms. Aim 2: To examine mechanisms of action
of MISSION in COD. Aim 3: To conduct a comprehensive economic evaluation of MISSION or its parts and
MOUD. Exploratory Aim: 4. To construct a predictive model to match optimum combined use of MISSION parts
with patient needs to improve health outcomes. This proposal is aligned with NIMH’s strategic plan goal 4 “to
increase the public health impact of services studies, investigators test ways to adapt, implement, and scale
effective interventions for varied populations across multiple service settings in a cost-effective manner.” Upon
completion, it could offer more cost effective, robust, personalized treatments.

Public health relevance
Narrative This application is aimed at augmenting Medication for Opioid Use Disorder (MOUD) usual care with a time- limited wraparound intervention called “Maintaining Independence and Sobriety through Systems Integration, Outreach, and Networking (MISSION) specifically for individuals with co-occurring opioid addiction and mental illness given that they have high rates of treatment discontinuation and poor outcomes. This is a 4-year, 5-arm RCT with a fractional factorial design among 1,000 patients across 9 MOUD programs to test the added benefit of MISSION or its components + MOUD compared to MOUD alone.